Control Of G Protein Signaling: Role Of The RGSs

We have shown that RGS proteins modulate signaling through a variety of G-protein coupled receptors including chemokine receptors. Chemokine receptors signal predominantly by triggering G alpha i nucleotide exchange. Humans and mice have three Gi isoforms although Gi alpha2 (encoded by Gnai2) and Gi alpha3 (encoded by Gnai3) predominate in lymphoid cells. We have found that Gnai2 -/- T and B cells have severe defects in chemokine-receptor signaling while Gnai2 +/- T and B cells exhibit modest defects. In vivo, the Gnai2-/- B cells fail to properly access lymph node follicles and the Gnai2-/- T cells failing to properly enter the T cell zone. We have studies the immune system with a focus on immune cell trafficking in various RGS deficient mice. We have supplemented these studies with in vitro studies using mRNA knock-downs as well as over expression studies using RGS proteins fused to a fluorescent marker. The recognition of the importance of both G-protein signaling and RGS proteins in the regulation of lymphocyte responses to chemokines has led us some of our studies to hematopoietic cell types. RGS1 has been linked to type 1 diabetes, celiac disease, multiple sclerosis, and melanoma progression. A prominent site of Rgs1 expression is in intraepithelial lymphocytes (IELs), which are found in the gastrointestinal tract (GI). IEL dysfunction has also been implicated in inflammatory diseases of the GI tract. In conjunction with Dr. Adrian Hayday (Kings College London Medical School) RGS1 was found to be selectively expressed at a much higher level in human gastrointestinal T cells in comparison to peripheral blood T cells, which was exaggerated in intestinal inflammation. RGS1 gain-of-function profoundly reduced T cell migration to specific lymphoid-homing chemokines, without significantly affecting random chemokinesis. Conversely, RGS1 loss-of-function enhanced directional chemotaxis, specifically in gut T cells. We also have begun a series of experiments to evaluate the role of Rgs1 in dendritic cells in collaboration with Dr. Brian Kelsall (NIAID, NIH, Bethesda, MD). RGS2 has been linked to hypertension and anxiety disorders and mice lacking Rgs2 exhibit reduced T cell proliferation and IL-2 production, which translates in an impaired antiviral immunity in vivo. Rgs2 is well expressed in B and T lymphocytes and neutrophils while high levels are found in mast and dendritic cells. We have recently acquired Rgs2-/- mice to analyze neutrophil and B cell function in these mice. RGS10 is among the best expressed RGS proteins found in numerous hematopoietic cell types. However, immune phenotyping of these mice has revealed surprisingly little. Recently we have found that these mice have T cells with ehanced intracellular calcium responses following CD3 crosslinking. In addition patch clamping of T cells from these mice has revealed that CD3 stimulation results in a prolonged activation of CRAC channels in these mice. RGS13 is strongly expressed in both human and mouse germinal center B cells and is often found highly expressed in human B cell lymphomas of germinal center origin. Rgs13 is also well expressed in mast cells and in adult T cell leukemia cells. To facilitate our studies of RGS13 and to provide a potential resource for in vivo imaging endogenous germinal center B cells we have generated mice where GFP (green fluorescent protein) has been knocked-in (KI) into the Rgs13 locus replacing the RGS13 coding sequence. Flow cytometry revealed high levels of GFP expression in germinal center B cells. Intravital microscopy documented the presence of brightly GFP positive cells in the germinal center region. In addition, an unknown strongly GFP positive cell type surrounds the lymph node follicle. Immune phenotyping of these mice revealed a normal B cell compartment with the exception of a 50% expansion in Peyers patches. Upon immunization the Rgs13-/- mice exhibit an enhanced extra-follicular antibody response, a slightly exaggerated germinal center response, and a disturbance of germinal center architecture. Analysis of mRNA expression in Rgs13GFP positive B cells revealed a marked enrichment in germinal center specific genes as well as genes involved in cell proliferation. The Rgs13-GFP KI locus has been crossed into HEL transgenic mice to permit the visualization of Rgs13 deficient B cell during the early stages of an antigen specific B cell response. Rgs14 is well expressed in lymphocytes and initially targeting in mice indicated that its absence resulted in embryonic lethality at the two cell stage. To analyze the role of Rgs14 in immune cells we created Rgs14LoxP mice. However, deletion of Rgs14 was not deleterious so we have analyzed mice globally lacking Rgs14 expression. In immune system, T and B lymphocyte development in Rgs14-/- mice appears normal. Examination of lymphocytes as well as myeloid cells in spleen, bone marrow, and peritoneum at 4-hour, 1-day, and 4-day post challenge in a thioglycollate peritonitis model revealed no significant differences. Rgs19 is well expressed in B lymphocytes and less so in T cells. It is also well expressed in stem cells and hematopoietic progenitors. GFP has been inserted into the RGS19 locus and appropriated targeted mice identified. Rgs19 GFP KI mice are born with a normal Mendelian frequency. Flow cytometry revealed that GFP is well expressed in mature B and T cells and in progenitors in the bone marrow. Consistently the Rgs19 GFP KI mice had an enlarged spleen and thymus compared to wild type mice. Chemotaxis experiments comparing wild type and RGS19-/- lymphocytes indicate significant increases to a panel of chemokines with the KO B cells. Serum levels of IgM, IgG2a, and IgG2b are elevated in these mice. Current studies are aimed understanding the pathogenesis of the splenomegaly and enhanced B cell responsiveness in the Rgs19-/- mice. A lack of phenotypes in some of the RGS deficient may result from the functional redundancy among the many RGS proteins that lymphocytes and other hematopoietic cells possess. As another approach to assessing the role of RGS proteins in these cells we have begun the analysis of mice with a Gnai2 G184S knock-in obtained from Richard Neubig (University of Michigan). This mutation renders Gi alpha2 resistant to the effect of RGS proteins. The Gnai2 G184S KI mice possess a striking phenotype verifying the overall important of RGS proteins in G-protein regulation. They have a marked reduction in peripheral T cells;an increase in mature T cells in the thymus;a thymocyte egress defect;an absence of many peripheral lymph node;a disorganized spleen architecture;splenomegaly;abnormal lymphocyte responses to chemokines;and reduced serum levels of IgG3, but increased levels of Ig2b. In a thioglycolllate-induced peritonitis model, recruitment of G184S knock-in neutrophils to peritoneum is strikingly hindered despite increased numbers of neutrophils in bone marrow and spleen. In contrast, a higher number of G184S knock-in large peritoneal macrophages and CD5 negative B cells are present in the peritoneal cavity. A major chore will be to sort out which RGS proteins are responsible for the various defects in the immune and inflammatory cells in this mouse.